2023 Enzymes, Coenzymes and Metabolic Pathways GRC and GRS

Project Summary
This proposal seeks partial support for the 2023 Enzymes, Coenzymes, and Metabolic Pathways
GRC/GRS. These meetings are scheduled for July 15–16 (GRS) and July 16–21 (GRC) at the
Waterville Valley Resort, in Waterville Valley, NH. The “Enzymes” GRC/GRS is the paramount
conference for scientists investigating the structure and function of enzymes and their role in metabolism
and disease. The long-term goals of this conference are to stimulate communication within the broad
research community with interests in the roles of enzymes in life’s essential biological processes. To
reach these goals, the GRC has developed a technical program of 36 speakers (28 invited and 8
selected from poster abstracts), and the GRS has assembled a program of 9 speakers (1 invited and 8
chosen from poster abstracts) as well as a Bioscience Careers Panel consisting of ~5 leaders from
various backgrounds. These oral presentations will disclose the most recent findings in enzymology,
experimental method development, as well as how these are implicated in disease. The GRC Chairs
have emphasized that these scholars reflect a diverse and inclusive backgrounds: half of the scheduler
speakers are women, and several are from underrepresented groups. We also hope to recruit attendees
from a similarly wide expanse of diverse backgrounds. Afternoon poster sessions provide an opportunity
for all attendees to share their discoveries with the broader scientific community. Of particular
importance is that these poster sessions encourage close interactions among both junior and senior
investigators. This proposal has high significance because the “Enzymes” GRC is a pivotal conference
for researchers investigating the mechanisms of biochemical reactions and provides a central venue
for the exchange of knowledge in this essential health-related field. From a healthcare perspective, this
proposal is highly significant due to its focus on the development of new enzyme-targeted drugs. A
major outcome of this proposal will be the continued elucidation of how enzymes, co-enzymes, and
metabolic pathways contribute to the development of new therapeutics, especially for the treatment of
infectious diseases and cancer.

Public health relevance
Project Narrative Enzymes and coenzymes enable almost all metabolic transformations within organisms. For this reason, knowledge of enzymes often plays a key role in the amelioration of disease. A major challenge for the enzymologist is to understand enzymatic transformations, in terms of both mechanism and cellular context, to treat and/or cure specific diseases. How these processes occur and what can be done to manipulate them to improve human health are central topics of our meeting.